Development and Applications of Reactions to Enable Molecular Rigidification

PROJECT SUMMARY
Rigidity is an important property of molecules that increases the likelihood of their success as drugs. Our goal
with support of this MIRA grant is to develop reactions that enable molecular rigidification. We describe a
research program that enables access to rigid small and medium sized-strained rings. Our innovative approach
to obtaining rigid molecules is to use sulfone anions as carbene surrogates. We will also develop new methods
to stabilize highly reactive alkylidene units using palladium catalysis. The knowledge gained from these studies
using reactive carbenes will also be used to enable skeletal editing of heterocycles. We will apply the reactions
developed in this proposal to synthesize complex natural products and their derivatives with tubulin binding
properties and antifungal properties.

Public health relevance
PROJECT NARRATIVE The proposed research details the development of reaction methodology to enable molecular rigidification. We will develop stoichiometric dialkyl carbene transfer reactions using alkyl sulfones as carbene precursors to obtain chiral orphaned cyclopropanes and apply this reaction to the synthesis medium-ring heterocycles and the synthesis of the antifungal compound jawsamycin. Simultaneously, we will study the mechanism of Pd and Ni- catalyzed dialkylcarbene transfer reactions, which will enable access to medicinally relevant bioisosteres such as [2.1.0]-bicyclopentanes (housanes), annulated heterocycles, and cerorubenic acids I, II and III.